Chemical synthesis of illudalic acid analogs for stimulant use disorder

PROJECT SUMMARY
The objective of this undergraduate-centered project is to develop innovations in chemical synthesis that
produce novel therapeutic lead compounds for stimulant use disorder.
Stimulant use disorder affects millions of Americans. Overdose deaths involving stimulants have increased
significantly in recent years, and they surged during the COVID-19 pandemic, especially in conjunction with
opioid abuse. There are no FDA-approved medications for stimulant use disorder, but the protein tyrosine
phosphatase receptor-type D (PTPRD) has been identified as an important therapeutic target. Genetic
studies link higher PTPRD expression levels with greater propensity for substance abuse and addiction, and
reducing PTPRD activity reduces cocaine-seeking behavior in mice. PTPRD inhibitors thus provide potential
new avenues for developing treatments for stimulant use disorder.
The natural product illudalic acid is a potent PTPRD inhibitor. Chemical synthesis of illudalic acid has been
prohibitively difficult, so a simplified analog known as 7-BIA emerged as a lead compound for targeting
PTPRD. 7-BIA was more synthetically accessible than illudalic acid but is less potent. Illudalic acid (and
7-BIA) is postulated to bind reversibly in the PTPRD catalytic domain, unmask a reactive dialdehyde, and
then ligate covalently to a key cysteine residue, irreversibly blocking PTPRD activity.
Synthesis of illudalic acid analogs is proposed. Preliminary results establish a convergent 5-step synthesis
(longest linear sequence, LLS) of illudalic acid, whereas prior approaches require 16-20 linear steps. The
key step here is a [4+2] benzannulation to assemble the fully substituted arene core and carbon framework.
Undergraduate students will develop the approach and related methodology for the synthesis and late-stage
functionalization of illudalic acid analogs, called “illudalogs”. Compounds will be evaluated for PTPRD
inhibitory activity and selectivity, alongside illudalic acid and 7-BIA as positive controls. The rationale for this
work is that illudalic acid-based PTPRD inhibitors can lead to pharmacotherapies for stimulant use disorder.
Three complementary aims focus on: (1) developing the synthetic chemistry of the illudalogs, including late-
stage functionalization and a new benzannulation; (2) building and maintaining a synthetic compound library
of diverse illudalogs for structure-activity relationship (SAR) studies and lead identification; and (3) creating
functional probes for PTPRD enzymology and cell biology. Expected outcomes include innovations in
chemical synthesis that provide transformative access to PTPRD inhibitors and probes. These outcomes
will support development of the therapeutic potential of PTPRD as a target for antiaddiction medication.

Public health relevance
PROJECT NARRATIVE This project focuses on innovations in chemical synthesis needed to develop medications for stimulant use disorder. PTPRD is an important therapeutic target for stimulant use disorder, and illudalic acid and related compounds inhibit PTPRD by a unique mechanism of action that creates opportunities for drug discovery.